NK cell-myeloid cell crosstalk in patients with cancer

PROJECT SUMMARY/ABSTRACT The tumor microenvironment has long-been known to be immunosuppressive. Many specific proteins have been identified that prevent adequate activation of infiltrating immune cells. It is not known, however, how tumor cells initiate an environment that allows survival in the presence of effector cells that have evolved to eliminate them. One such effector cell in the antitumor response is the natural killer (NK) cell, which secretes inflammatory cytokines and directly kills transformed cells. There is significant evidence to support the involvement of NK cells in the elimination of transformed cells in the early stages of tumor development. At some point, through an unknown mechanism, transformed cells establish a method to escape recognition by these cells and a solid tumor develops. Once a tumor is established, the ability of cytotoxic immune cells to eliminate tumor targets is severely diminished, allowing tumor growth and further suppression of local and systemic immunity. There is also extensive recruitment of myeloid cells, believed to promote angiogenesis and metastasis, and prevent immune cell activation. Using cellular and molecular biological techniques, we will study the complex interactions between tumor cells, the myeloid cells that they recruit and NK cells in patients with glioblastoma. We hypothesize that myeloid cells are recruited to protect tumor cells from immune recognition, and may serve as decoy targets for NK cells in patients with cancer. My research plan details my immediate and long-term career goals in understanding the cellular and molecular mechanisms that govern tumor suppression of local and systemic immunity. My immediate goals are to define the impact of a tumor on NKG2D-ligand expression by myeloid cells and how these myeloid cells can, in turn, regulate the function of NK cells. We hypothesize that through induction of NKG2D ligands on the surface of myeloid cells, NK cell killing is redirected from tumor cells to the massive infiltration of myeloid cells. If these NKG2D ligand positive myeloid cells serve as decoy targets for NK cells, a tumor will have created a physical barrier and promote survival, angiogenesis and metastasis shielded from the cytotoxic cells of the immune system. We have shown that NKG2D ligand-positive myeloid cells can be targets for NK cells, and that tumor- derived soluble proteins induce NKG2D ligand expression on myeloid cells. In this proposal, we will first evaluate NK cell function in response to NKG2D ligand expressing myeloid cells from patients (Aim 1). We will next determine if NKG2D ligand expression by myeloid cells in patients with cancer can be used as a diagnostic or prognostic tool (Aim 2). Furthermore, we will isolate and identify the tumor-derived soluble protein or proteins that induce NKG2D ligands on myeloid cells (Aim 3). Altogether, this research effort will have important clinical relevance and will influence clinical management of patients with brain, hepatocellular, prostate, and breast cancer. My long-term goals after becoming an assistant professor include forming an interdisciplinary basic and clinical research program to explore how a tumor influences innate and adaptive immune responses in patients. Using animal models and patient samples, I aim to discover mechanisms of tumor immunosuppression and develop improvements to current immunotherapy for patients with cancer. I will complete the mentored phase of this proposal under the guidance of Drs. Andrew Parsa and Lewis Lanier and look forward to completing the independent phase of this project as an assistant professor at another university.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The focus of my research has been aimed at defining the impact of tumor burden on the function of cytotoxic immune cells in patients with glioblastoma. This work will have broad implications in the development of novel patient therapies that capitalize on improvements of Natural Killer and CD8+ T cell function. The work proposed in this application will identify a potential mechanism of immune evasion by glioblastoma. This project may also be widely applicable to monitoring at risk patient populations using a novel biomarker for cancer. Finally, this project will identify a novel soluble protein target for immune therapy in glioblastoma and possibly in other cancer patients. By gaining a better understanding of how tumors can systemically and locally impact cells of the immune system, and mechanisms for tumor escape of immune recognition, we hope to improve preventative and therapeutic approaches in the battle against cancer. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Our long-term goals are to: 1) understand the effects of a tumor on immune cells for optimizing cancer patient immunotherapy, and 2) develop a novel, non-invasive technique to monitor tumor recurrence in patients. Immune surveillance by Natural Killer (NK) cells is critical to eliminating tumor cells and preventing establishment of solid tumor. One major mechanism of NK cell activation is through the NKG2D receptor. Activated NK cells reject NKG2D ligand-expressing tumors in mouse models, and human NK cells lyse tumor cells through NKG2D-mediated activation. Recent studies have demonstrated a strong association between myeloid cell accumulation in tumors and tumor size, angiogenesis, and metastasis. Here we provide preliminary evidence that a variety of human cancers induce the expression of NKG2D ligands on circulating myeloid cells. In patients with glioblastoma (GBM), a deadly type of brain tumor, NKG2D ligand expression on myeloid cells is independent of steroid treatment, surgical intervention, and chemotherapy. Transwell assays indicate that myeloid cell expression of NKG2D ligands is a consequence of a soluble factor or factors produced by tumor cells. NKG2D ligand expression on circulating myeloid cells is sufficient to induce inflammatory responses by activated NK cells that are dependent on NKG2D. Based on these data, we hypothesize that tumor-derived soluble factors induce NKG2D ligand expression on circulating myeloid cells, causing activated NK cells to preferentially attack myeloid cells instead of NKG2D ligand expressing tumor cells. In this proposal, we will determine the functional consequences of NKG2D ligand expression by myeloid cells on NK cell responses. We will next validate the use of NKG2D ligands on myeloid cells as a biomarker in human cancers, including GBM, breast, prostate and hepatocellular carcinomas. Finally, we will identify the soluble factor that induces NKG2D ligand expression on myeloid cells. We will pursue the following specific aims to test this hypothesis: Specific Aim #1: Determine functional consequences of NKG2D ligand expression by myeloid cells in GBM patients. It is not known whether myeloid cells that express NKG2D ligands have a positive or negative effect on anti-tumor cell immune responses mediated by NK cells. Using chromium release and flow cytometry assays, we will quatitate the impact of NKG2D ligand expressing myeloid cells from the circulation of GBM patients on NK cell lysis of labeled autologous tumor targets. We will also determine the effect on tumor cell induced production of interferon gamma (IFNg) by NK cells. These studies will reveal the impact of NKG2D ligand expressing myeloid cells on the effector functions of GBM patient NK cells. We will also determine the impact of localization in the tumor microenvironment by isolating tumor infiltrating myeloid cells and NK cells and repeating the assays described for circulating cells. Specific Aim #2: Determine the utility of NKG2D ligand expression by myeloid cells as a biomarker. We will determine the percentage of patients with GBM, breast, prostate and hepatocellular carcinomas who express NKG2D ligands on myeloid cells in circulation relative to control patients. We have validated an approach for NKG2D ligand expression on myeloid cells using flow cytometry and quantitative PCR from patients using a small volume of peripheral blood. We will also determine if myeloid cells from patients with GBM express NKG2D ligands before and after surgical intervention. Patients with other types of cancer will be monitored during treatment to assess the association between NKG2D ligand expression and tumor burden. These clinical studies will determine the feasibility of using NKG2D and NKG2D ligand expression as a biomarker for patients with a variety of solid tumors as a minimally invasive technique. Specific Aim #3: Identify the mechanism of NKG2D ligand induction on myeloid cells. We have developed a robust system for inducing and detecting NKG2D ligand expression. Using this system, we will take an unbiased protein approach to purify the tumor-secreted protein that induces NKG2D ligands on cultured myeloid cells. We will also take a candidate approach to evaluate the NKG2D-ligand inducing ability of a panel known soluble proteins produced by GBM cells. In subsequent in vitro experiments, we will inhibit purified protein activity with siRNA and blocking antibodies to validate the protein(s) ability to induce NKG2D ligand expression on myeloid cells. We will also overexpress the protein(s) to determine if this is sufficient to induce NKG2D ligand expression. Identification of tumor-derived factor(s) that induce myeloid cell NKG2D ligand expression may reveal novel targets for optimizing cancer immunotherapy. These studies will provide insight into how a variety of cancer types facilitate an immunosuppressive state indirectly through modulation of myeloid cells. The molecular features of this immunosuppressive cascade could have immediate clinical implications, particularly within the context of active immunotherapy trials. In addition, these experiments have the potential to reveal a novel biomarker of tumor recurrence, progression, or an overall measure of tumor burden that can be easily applied to a variety of cancer patients.